Discovering Spatial Mechanisms Regulating Metastatic Invadopodia in PDAC

There is a major need for new therapeutic strategies that target Kras in pancreatic ductal adenocarcinoma
(PDAC) which has a dismal 5% survival rate. However, over 3 decades of work has failed to develop
effective therapeutics against Kras or other mutant Ras isoforms (Hras, Nras), which account for
approximately 30% of all human cancers. Recent published work in our laboratory revealed that
mutationally activated Kras drives its own protein synthesis using a positive feedforward mechanism and
the unique translation elongation factors eIF5A1. In fact, Kras drives increased eIF5A1 expression which
in turns drives increased in Kras translation and downstream signaling, leading to increased cell
proliferation and migration. More recently, we tested the ability of the highly related isoform eIF5A2 to
regulate this pathway. Surprisingly, we discovered that eIF5A2 does not regulated Kras expression nor
does it regulate PDAC cell growth, but rather it plays a unique role in regulating invadopodia formation
and metastasis, which operates independent of eIF5A1. The identification that eIF5A2 mediates
invadopodium formation and metastasis is an important breakthrough because it provides a new therapeutic
strategy to target metastatic PDAC, which is sorely needed. In fact, unlike eIF5A1, which is ubiquitously
expressed in tissues, eIF5A2 expression is restricted to brain and testis, but is selectively upregulated in
malignant PDAC tissues and metastases making it an ideal biomarker and therapeutic target. Therefore,
work outlined in this proposal will test the hypothesis that eIF5A2 regulates localized translation of mRNAs
encoding key metastatic proteins that drive PDAC cell invasion and metastasis using the clinically relevant,
immune competent, KCP mouse model of PDAC metastasis. The proposed work is important because the
mechanisms that regulate mRNA translation in the invadopodium are poorly understood in general and
have not been investigated in PDAC. A detailed understanding of this process could reveal new strategies
and targets to modulate eIF5A2 protein expression, invadopodium formation, and PDAC metastasis. Such
an approach is sorely needed for development of new and existing therapeutics to fight this deadly disease.
Specific Aim 1. To determine the role of 5A2 in mediating 5A2, erbB2, PDGFR-b, and PEAK1 mRNA
localization, translation, and signaling in invadopodium formation and cancer cell invasion.
Specific Aim 2. To determine the role of 5A2 in mediating PDAC tumor formation and metastasis.

Public health relevance
Pancreatic cancer is a deadly disease because of the high incidence of systemic metastases at the time of diagnosis and the lack of sufficient therapeutic agents. The overall objective of this proposal is to determine if eIF5A2 protein regulates invadopodium formation to drive metastatic pancreatic cancer using preclinical mouse models that closely recapitulate the human disease.